GLOBAL SCREENING ARRAY (GSA) - GENETIC STUDY OF NEURAL TUBE DEFECTS

Genetic Study of Neural Tube Defects, high throughput genotyping and DNA sequencing for studying the genetic contributions to human health and disease.